Adipsin in NASH

Project Abstract
The obesity pandemic brings with it multiple attendant metabolic comorbidities, including Non-Alcoholic Fatty
Liver Disease (NAFLD). NAFLD is now the leading cause for chronic liver disease, with prevalence approaching
30% in certain populations, but may in fact be considered a “pre-disease” state for Non-Alcoholic Steatohepatitis
(NASH) and associated liver fibrosis. NASH has no approved pharmacotherapy, and is thus the fastest-growing
reason for liver transplantation. As the prevalence of obesity-related NASH continues to rise, and available livers
for transplantation remain limiting, this unmet need grows more urgent.
Intercellular crosstalk between lipid-laden hepatocytes and non-parenchymal cells (NPCs), including hepatic
stellate cells (HSC), determine obesity-induced liver pathology. To determine signals that mediate hepatocyte-
NPC crosstalk, we performed transcriptomic analysis in hepatocytes isolated from mice fed a NASH-provoking
diet. When compared to normal chow-fed mice, we found significantly increased expression of Cfd (Complement
factor d), which encodes Adipsin, a secreted protein thought uniquely produced in adipocytes that mediates
complement factor C3 cleavage. We first confirmed these data in three other dietary NASH mouse models, as
well as in liver biopsies from patients with NASH, all of which revealed increased liver (but not adipose) Adipsin
in NASH. These robust correlations prompted us to test potential of Adipsin to mediate NASH phenotypes. First,
as Adipsin cleaves complement factor C3 to two bioactive species – C3a, which binds C3aR1 on target cells,
and C3b that drives alternative complement pathway activation – we analyzed C3 knockout mice fed NASH diet,
which showed lower fibrosis than controls. Next, we transduced NASH diet-fed wildtype mice with a viral vector
encoding shRNA to Cfd, which phenocopied lower fibrosis seen in C3 knockout animals, in both prevention and
treatment strategies. Consistently, application of recombinant C3a increased HSC activity in vitro. These results
suggest that aberrant liver Adipsin plays a pathogenic role in NASH, which we will test in Aim 1 of this application,
including studies to test whether Adipsin-derived C3a acts directly on HSC C3aR1 to drive liver fibrosis. In Aim
2, we study mechanistic determinants of aberrant liver Adipsin in NASH. Preliminary data revealed a striking
induction of the master adipogenic factor PPARγ2 in mouse and human NASH. These data prompt the
hypothesis that a PPARγ2-mediated adipogenic reprogramming of hepatocytes in NASH is necessary and
sufficient to drive Cfd expression in the obese liver. Achieving the goals of this application will identify mechanistic
determinants of aberrant Adipsin expression and resultant liver pathology, and potentially lead to development
of Adipsin or C3aR1 inhibitors for NASH-induced fibrosis.

Public health relevance
Project Narrative Non-Alcoholic Fatty Liver Disease (NAFLD) is the most common chronic liver disease, with prevalence growing in parallel with the obesity epidemic. NAFLD has no approved pharmacotherapy, due to incomplete understanding of its molecular mediators which is compounded by its unpredictable progression to liver fibrosis, the major determinant of morbidity/mortality of this disease. In this application, we study the potential role of hepatocyte-derived Adipsin, previously considered an adipose-specific secreted factor, to induce liver fibrosis.